Administrative Core

ABSTRACT – CORE A
The overall goals of the Administrative Core of the Program Project Grant (PPG) are to provide general
scientific, programmatic and fiscal leadership, facilitate lines of communication between the different
researchers involved in the PPG, maintain coherence in the PPG's overall and long-range goals, coordinate
data analysis and sharing, monitor human subjects issues and issues related to the use of vertebrate animals,
and ensure that resources resulting from the PPG will benefit the scientific community. In the context of the
above, the tasks of this Core include effective coordination of activities in the four Research Projects and the
Bioinformatics Core to best achieve the overall goal of elucidating the mechanisms through which DNA
damage drives important aspects of aging and age-related diseases and how certain genome maintenance
genotypes found associated with extreme human longevity can preserve genome integrity over longer periods
of time. Well-coordinated activities of the Projects and Cores will promote the mobilization of new human data
sources and analysis techniques that will allow us to more specifically test the functional impact of DNA
damage and its various end points, providing computational and statistical services to all members of the PPG
as needed and providing access by the scientific community to the PPG's resources, information and
technologies through the internet.

Public health relevance
PROJECT NARRATIVE – CORE A Core A will coordinate the research in this Program Project Grant (PPG), which has its members at different geographical locations. Through its Director, Dr. Jan Vijg, its Administrator, Ms. Stephanie Alfieri, and its Administrative Assistant, Ms. Yolanne Blake, Core A will organized the necessary teleconferences, meetings, exchange visits, etc., to hold this PPG together and create an atmosphere of collegiality, in which the focus is on collaboration, with results interpreted in an integrated manner across all research projects.